Attentional Ability and Resilience to Alcohol Use Disorder: Neurocognitive Mechanisms

PROJECT SUMMARY
A family history (FH) of alcohol use disorder (AUD) increases one’s personal risk of AUD by 3-4 fold. Given the
large proportion of the burden of AUD endured by these individuals and their families, the development of
impactful prevention and treatment strategies should consider focused strategies for those individuals. A
compelling approach to accomplish this goal is to augment brain resilience mechanisms to compensate for
underlying vulnerabilities, which would have greatest efficacy in those at highest risk for poor outcomes. With
this objective in mind, we previously identified candidate neurocognitive mechanisms of resilience to familial risk
for AUD by comparing FH-positive young adults with versus those without AUD relative to controls. Using this
resilience-centered framework, a well-powered, data-driven analysis identified self-reported attentional ability as
the factor that most robustly predicted AUD resilience. We validated this finding in a large, independent sample,
demonstrating that at-risk young adults with FH that do not binge drink report heightened attentional ability, not
only relative to those that binge drink, but even relative to low-risk, non-binge-drinking young adults, supporting
the notion that attentional processes support resilient outcomes to AUD and binge drinking. We now seek to
advance these cross-sectional, self-report associations in a rigorous, systematic investigation to identify
targetable cognitive processes and brain regions that promote AUD-related resilience. Currently, the
mechanisms linking attentional ability to AUD resilience remain undetermined. The proposed studies seek to
establish how attentional ability protects against the development of alcohol use disorder in at-risk individuals by
combining both observational and experimental methods. In Aim 1, we will examine the role of facets of attention
measured with fMRI, EEG, and behavior on alcohol use trajectories in 200 emerging adults, including those at
risk (FH-positive) and those not at risk (FH-negative) for AUD. The neural correlates of the relationship between
attentional ability and future alcohol use will be examined with computational analyses of fMRI and EEG data
acquired during attention tasks. In Aim 2, we will test whether fMRI and EEG markers of attention attenuate
neural responses to pictorial alcohol cues as a mechanism of AUD resilience. In these two longitudinal aims, we
predict that greater “top-down” neurobehavioral indicators of attentional ability (Aim 1) will promote reduced
“bottom up” cue reactivity (Aim 2), resulting in shallower alcohol use trajectories in FH-positive (vs. FH-negative)
individuals. Aim 3 will include a subsample of 50 “non-resilient” subjects reporting problematic alcohol use. We
will test causal relationships by examining effects of boosting attentional ability with methylphenidate on neural
cue reactivity (as a proxy for addiction) in a placebo-controlled, within-subjects study. Successful completion of
this project will substantially increase our understanding of the neuroscience of resilience related to addiction.
This knowledge will support the development of treatment and preventive strategies that could significantly
mitigate alcohol-related problems in the millions of individuals in the US with familial risk.

Public health relevance
PROJECT NARRATIVE Most cases of alcohol use disorder develop between adolescence and young adulthood, and individuals with a family history are at 3-4 times increased risk. An examination of the neural and behavioral mechanisms of resilience that moderate the development of pathological alcohol use in individuals with a positive family history of AUD can inform treatment and prevention strategies for those most at-risk.